Multi-morbidity 3-City Alzheimer's Disease EHR Study (M3AD Study)

The overall goal of our proposal is to place patients impacted by Alzheimer’s Disease (AD) and Related Dementia
(AD/ADRD), rather than the disease, at the center of the research in order to better tailor risk prediction, enable
individualized prevention, and improve clinical outcomes and management of these patients in their layered
complexity. Our point of departure is the recognition that chronic diseases, including AD/ADRD, do not exist
solely as isolated entities. Instead, we acknowledge that their shared organic substratum and common sets of
risk and protective factors contribute to determining concomitant trajectories of multiple diseases, mutually
influencing each other’s course and natural history, in ways yet unexplored. The use of large longitudinal datasets
such as electronic health records (EHRs) thus becomes a key novel asset with potential to advance
understanding and management of dynamic personalized risk in the layered complexity
involving variations
through risk factors, and concomitant diseases. Thus, we propose to federate a multiethnic 3-city EHR
consortium (New York Presbyterian’s: 6 million patients (33,000 with AD/ADRD;23% Hispanic); University of
Chicago: 2 million patients (11,000 with AD/ADRD; 60% Black); and University of Miami:1.4 million patients
(13,000 with AD/ADRD; 50% Hispanic). Further, mindful that EHRs often overlook social variables (e.g.,
race/ethnicity, education, income), known to alter dementia risk, we will embed these EHRs in census-track level
social determinants of health data to pursue the following specific aims: Aim 1 –Determine and quantify whether
and how: trajectories of multimorbidity (timing, order of incidence, level of control/management, evolution) predict
the incidence, timing, and progression of AD/ADRD, over years of longitudinal EHRs; and whether the
relationships between those trajectories and AD/ADRD are modified by gender, race/ethnicity, age, education,
place of birth, and other socioeconomic factors (1.a); and changes in specific multimorbidity risk factors (smoking,
weight) and manageable aspects of care (blood pressure control, glycemic control) impact the incidence, timing,
and progression of AD/ADRD (1.b). Aim 2 –Determine and quantify whether and how complexity patterns of
multimorbidity, complexity of care management, and patient complexity predict (2.a) and impact (2.b) the
incidence, timing, and progression of AD/ADRD over years of longitudinal EHRs, and whether those factors are
affected by gender, race/ethnicity, age, education, place of birth, and other socioeconomic factors. Aim 3 –
Determine the supplementary value of “enriched” EHR with research items already collected for participants
concomitantly enrolled in research cohorts, to refining identified trajectories and complexity patterns. We have
assembled an interdisciplinary complementary network of innovative researchers and will use machine learning
and novel dynamic predictive and causal inference methods to identify accelerators or decelerators of AD/ADRD.
This work will inform strategies to tailor risk prediction, and complex clinical management. It will also build a
multiethnic harmonized dynamic platform ready for real-world evaluation of future treatments of AD/ADRD.

Public health relevance
Project Narrative Recognizing that chronic diseases, including Alzheimer’s Disease (AD) and Related Dementia (AD/ADRD), do not exist solely as isolated entities, the use of large longitudinal datasets such as electronic health records (EHRs) becomes a key novel asset with potential to advance understanding and management of dynamic personalized risk in the layered complexity involving variations through risk factors, and concomitant diseases. Thus, we propose to federate a unique multiethnic 3-city EHR consortium in NY, Miami and Chicago, encompassing 9 million patients records (59,000 of them with AD/ADRD) embedded in census-track level social determinants of health, and to use machine learning and novel dynamic predictive and causal inference methods to identify accelerators or decelerators of AD/ADRD. This work will inform strategies to tailor risk prediction, inform complex clinical management and build a multiethnic harmonized dynamic platform ready for real-world evaluation of future treatments of AD/ADRD.